Data Management and Analysis Core

PROJECT SUMMARY/ABSTRACT
The broad, long-term goal of the Data and Life Sciences Core (DLSC) within the Nebraska Center for Integrated
Biomolecular Communication (CIBC) is to serve as a critical, sustainable resource for biomedical data science
and data management expertise, service, and education at the University of Nebraska. The research performed
by CIBC investigators will continue to result in the creation of large, complex data sets, particularly for those
researchers with projects involving high-throughput biological data and molecular biology data. Proper
experimental design, data generation, and subsequent analyses of these data sets requires analytical and
computational expertise, access to scientific equipment and relevant technical expertise, high-throughput
computing, and resources for data management. Coordinated access to such services is often cost prohibitive
and nonintuitive for individual laboratories. Another obstacle faced by many biomedical researchers, including
those affiliated with CIBC, is the timely and comprehensive sharing of research data and research findings with
collaborators, stakeholders, and the public. To address these issues, CIBC will continue to support DLSC. DLSC
provides hardware, software, and expertise in experimental design, bioinformatics, computational biology,
statistics, computer science, data management, and advanced cyberinfrastructure to CIBC investigators and the
wider university community. To date, DLSC has launched a web portal for data transfer, hosting, and sharing
through Globus and the University of Nebraska’s Holland Computing Center; initiated collaborations with CIBC
researchers leading to presentations and publications; provided access to analytical software; and hosted
training and workforce development opportunities. The immediate goal of DLSC for Phase 2 is to expand and
strengthen the core’s data science and data management infrastructure, services, expertise, and educational
programming in support of CIBC investigators and the Center’s overall goals and long-term sustainability. This
will be achieved through four aims: 1) expand an existing computational platform for data storage, analysis, and
management to include support for biomolecular imaging experiments and integration with the Research Space
platform, 2) promote core sustainability by initiating collaborations with personnel across the University of
Nebraska campuses to enable complex, interdisciplinary biomedical projects that require expertise in data
science and data management, 3) serve a critical, sustainable role in CIBC research by collaborating on CIBC
projects, both as authors on research publications relevant to CIBC and as investigators on subsequent
proposals for internal and external research funding, and 4) educate CIBC members about the role of data
science in chemical and biochemical research, the potential and caveats of experimental data, and start-of-the-
art resources and pipelines for data preprocessing and analysis. DSLC will continue to capitalize on existing
expertise at the University of Nebraska, hire needed expertise, and build long-term core sustainability.